Central Amygdala Vasopressin Activity in Withdrawal-Related Affect from Chronic Adolescent Binge Episodes

PROJECT SUMMARY
Withdrawal from alcohol exposure is associated with alcohol use disorder, but much remains unknown about
withdrawal responses during adolescence in males and females. Our lab utilizes a chronic exposure paradigm
of adolescent binge alcohol exposure that results in increased social anxiety (indexed via reduced social
interaction in the modified social interaction test) in both sexes. However, a sex-specific increase in pro-stress
neuropeptide vasopressin (AVP) is evident in males, but not females in the central amygdala (CeA), supporting
that sex-dependent mechanisms may drive anxiogenic responses during withdrawal from alcohol. This proposal
is designed to test the overarching hypothesis that social dysfunction during acute withdrawal from repeated
binge episodes during adolescence alters the functional properties of sex-specific CeA neurons implicated in
anxiety, with withdrawal-related activation of the AVP system within the CeA mediating these effects in male but
not female rats. This hypothesis will be tested in Aim 1 by determining which GABAergic subtypes in the CeA
are activated during social interaction following acute ethanol withdrawal, and if the GABAergic properties of
activated neurons are changed by withdrawal. In Aim 2, we will assess the co-localization of AVP receptor (V1aR
and V1bR) mRNA in CeA neuron subtypes activated during social interaction, and if bath application of AVP
receptor antagonists changes the GABAergic properties of activated neurons. Behavioral analysis will then be
done to test whether systemic AVP receptor antagonism reverses social behavior alterations following repeated
adolescent binge episodes in both males and females. Collectively, these studies will assess CeA-specific
neuronal mechanisms related to social behavior during withdrawal from chronic adolescent binge ethanol
exposure and address the role of the AVP system. Training will incorporate multiple techniques, and the guidance
of my mentorship team will provide me with crucial skills to broaden my conceptual and technical repertoire,
along with necessary professional development to provide the framework towards attaining a postdoc position
and pathway towards being an independent scientist.

Public health relevance
PROJECT NARRATIVE Adolescent binge alcohol exposure and accompanying repeated withdrawal states are harbingers for the development of alcohol use disorder in adulthood. This proposal will investigate how withdrawal from chronic adolescent binge alcohol exposure alters brain regions associated with anxiety and assess the contribution of a select neuropeptide system to alleviate social anxiety-like behavior induced by withdrawal from alcohol.